LC-ACC interactions supporting adaptive, feedback-driven decisions

PROJECT SUMMARY/ABSTRACT
Our long-term goal is to understand how the brain processes information in a flexible, context-dependent
manner to support effective decision-making. Many previous studies of decision-making focused on how the
brain accumulates evidence used to select a particular action, which was shown to involve modulations of
persistent activity of individual sensory-motor neurons that prepare the appropriate action. However, the brain
must also often accumulate evidence in a flexible manner across actions, about which little is known. We
propose that decisions requiring the flexible accumulation of feedback-related evidence across actions
depends on interactions between the Anterior Cingulate Cortex (ACC), a cortical structure on the medial
surface of each cerebral hemisphere that has widespread connectivity with other parts of the brain, and the
brainstem nucleus locus coeruleus (LC), which is the primary source of the neuromodulator norepinephrine
(NE) to the rest of the brain. The ACC and LC have strong, reciprocal connections and are thought to interact
in ways that support key features of cognition, including adaptive information processing, but the details of
these interactions are not well understood. Our primary hypothesis is that these interactions modulate activity
patterns of populations of ACC neurons that implement a process of across-trial evidence accumulation that
uses reward and error feedback to govern decisions to switch behavioral choices. We are particularly
interested in understanding how these modulations relate to changes in coordinated variability in ACC that can
have major effects on how neural populations process information. To test this hypothesis, we use
simultaneous, complementary measurements of neuronal activity from single and populations of neurons from
the two brain areasin the context of two tasks that require different forms of across-trial accumulation of
feedback information to guide saccadic decisions. We have three Specific Aims. Aim 1 is to understand how
activity patterns of individual neurons in the LC relate to performance on these tasks. Aim 2 is to understand
how relationships between neuronal activity patterns in the LC and ACC relate to performance on these tasks.
Aim 3 is to use a combination of manipulations to identify causal contributions of temporally precise, pathway
specific activity patterns from LC to ACC on task performance. Together these Aims will provide new
mechanistic and computational insights into how LC-related modulations of ACC population activity support
ACC's role in flexibly linking performance monitoring and control across multiple trials. Our findings will have
direct relevance to numerous constructs in the Research Domain Criteria (RDoC) framework and thus have
broad significance to fields that aim to understand the neural substrates of complex behaviors and their
dysfunction in certain mental disorders.

Public health relevance
PROJECT NARRATIVE The proposed work is basic research that aims to generate new insights into how a healthy nervous system can flexibly process reward feedback to guide effective decision-making. These studies are aligned with several constructs in the NIMH Research Domain Criteria (RDoC) and are intended to provide direct benefits to public health in the longer term, as these new insights can be used to design new ways to diagnose and treat disorders of mental health.